Mortality and hospital admissions risks from fine particulate matter by source sector and fuel: A national analysis

ABSTRACT
There is an urgent need to understand the health impacts of alternative climate change mitigation policies. Such
policies can impact various source sectors (e.g., transportation), fuel type (e.g., coal) and chemical composition
of fine particulate matter (PM2.5). Detailed characterization of the health consequences of exposure to PM2.5
sources and chemical composition will provide timely guidance to develop the most effective interventions for
both climate change and air pollution mitigation in the present day. The National Academy of Sciences, Health
Effects Institute, US EPA, and Global Burden of Disease have all identified understanding health outcomes of
air pollution sources as a critical research need. Prior studies suffer from the inability to identify relative
contributions of sources and fuel types to pollutant mixtures, quantify uncertainties, or apply rigorous cross-
validation, often due to lack of appropriate data and approaches. Most past analyses have inherently assumed
that all PM2.5 mass is equally toxic, regardless of source or composition; in fact, PM2.5 is the only air pollutant
regulated without regard to chemical form. To address this knowledge gap, we will conduct a nationwide analysis
to determine which PM2.5 source sectors and fuel types are most associated with mortality and cardiovascular
and respiratory hospital admissions. We will employ 2 large, well-characterized datasets (Medicare: >60 million
>200,000 participants with detailed data on
>100 individual-level variables). Using multiple approaches, including causal inference, we will test the
hypothesis that health impacts of PM2.5 vary by pollution source and/or combustion type for total mortality and
cardiovascular and respiratory hospital admissions. We will estimate and validate PM2.5 exposure by chemical
components (e.g., sulfate, organics, black carbon), source sectors (e.g., transportation, wildfires), and fuel types,
including fossil fuels (e.g., liquid oil and natural gas, solid biofuel), for the continental US for 2000-2023 at
monthly, ZIP code-level resolution by harmonizing data from satellites, air quality models, emissions inventories,
and monitors (Aim 1). We will evaluate how associations between PM2.5 and health vary by subpopulation (i.e.,
race, age, sex, socioeconomic status), addressing critical environmental justice concerns. We will apply well-
established approaches, modified for our analysis, to estimate exposure-
interpretation, for PM2.5 components, source sectors, and fuel types (Aim 2). We will ensure computational
scalability and account for uncertainty in estimated exposures, unmeasured confounding bias, and co-pollutants.
-specific (cardiovascular, neurological, asthma, other respiratory)
hospital admissions by PM2.5 constituent, sector/fuel type, and subpopulation (Aim 3). This work will help air
quality and climate policymakers prioritize mitigation efforts for specific PM2.5 sources and fuel types to maximize
health benefits. Findings will inform assessments of health effects of PM2.5 exposure and co-benefits of climate
change policies. We will disseminate new exposure data, causal inference applications, and statistical code.

Public health relevance
PROJECT NARRATIVE Ambient air pollution harms health on a global scale, yet little is known about which source sectors or fuel types emit the most harmful mixtures of pollutants. We will perform the first nationwide study of the risks for mortality and cause-specific hospital admissions associated with sub-chronic exposure to fine particulate matter (PM2.5) and identify which types of particles are most harmful by chemical components (e.g., sulfate, organics, black carbon), source (e.g., transportation, wildfires), and fuel type including fossil fuels (e.g., liquid oil and natural gas, solid biofuel), using innovative exposure methodology with traditional and novel statistical approaches. Results will provide scientific evidence as to which air pollution sources should be reduced to achieve the greatest human health benefits, improve our ability to effectively address environmental health disparities, offer new causal inference methods and exposure data that we will make publicly available, and inform studies of the health consequences of PM2.5 levels, including studies of the co-benefits of climate change mitigation policies.